Instrumenting the Fetal Membrane on a Chip

The first time the immune system can respond to a pathogen is in utero during infections
of the fetal membrane. Infection involving the fetal membranes is extremely difficult to
study in utero, both because of inaccessibility and the nature of the complicated
interface between mother and child. Thus, studies of pregnancy-related conditions
benefit from an in vitro model of the fetal membrane, i.e., a highly instrumented fetal
membrane on a chip (IFMOC). Specifically, the overarching goal of this research project
is to apply multidimensional analytical technologies and microfluidics engineering design
to define immune response biosignatures of infection in the in vitro fetal membrane.
Given these signatures, our ultimate long-range goal for this bench-to-bedside research
program is to develop a simple, inexpensive, and robust lab-on-a-chip system that will
permit accurate etiologic diagnosis of infections early during the course of illness based
on systemic host-response signatures of infection. We will also utilize sensitive and
specific methodologies to differentiate acute infections from pre-existing chronic
infections and/or asymptomatic microbial colonization. This work will be based on a
fundamental understanding of the human systems biology of infectious diseases and will
benefit from recent advances in organ-on-chip microfluidics, optical, amperometric, and
enzymatic sensors, and mass spectrometry. Our initial multianalyte sensor profiles are
focused on cellular bioenergetics using glucose consumption and lactate production and
oxidative burst by superoxide production measured by our microfabricated amperometric
sensors as well as MIC-1 protein secretion by the quartz crystal microbalance;
subsequently these signatures will be expanded with ion mobility-mass spectrometry
(IM-MS).

Public health relevance
Project Narrative During pregnancy, the fetus develops within a collection of amniotic fluid, surrounded and protected by an anatomical barrier known as the fetal membranes. Infection of the fetal membranes, known as chorioamnionitis, is a common cause of pregnancy complications (such as preterm birth, stillbirth, and infection of the newborn), yet the absence of a robust model to study the human fetal membranes has stifled development of new interventions to prevent chorioamnionitis. In this project, we propose to establish and implement an instrumented fetal membrane on a chip that will support detailed studies of bacterial chorioamnionitis and accelerate the discovery of new solutions that improve human reproductive health.